Screening strategies and social determinants of health among people with high risk of anal cancer

Abstract:
The incidence of anal cancer has almost doubled during the past decades, along with increased advanced
disease and mortality. Persistent high-risk human papillomavirus (hrHPV) infection leads to anal high-grade
squamous intraepithelial lesion (aHSIL), the precursor for anal cancer. Anal cancer risk is also exceptionally
high among certain groups: people living with HIV, men having sex with men (MSM), and women with lower
high-grade anogenital tract diseases. Health disparity further contributes to this high rate, as minorities, such
as Black MSM, have a significantly higher rate of aHSIL and cancer. Thus, early detection of aHSIL,
particularly among high-risk minorities, is crucial to reduce cancer incidence and disease burden. However,
the current recommendation for aHSIL screening is based on expert opinions, and research on high-risk
minorities is scarce. Thereby, we propose this large multisite study to investigate potential screening markers
for aHSIL, with a specific focus on high-risk minorities. Furthermore, only a small portion of those diagnosed
with aHSIL will develop cancer, yet the treatment recommendation is for all aHSIL, resulting in significant over-
treatment, leading to unnecessary side effects and increased cost. It is crucial to develop reliable markers to
stratify risks of aHSIL progression and regression. Given the importance of local DNA methylation and the
immune environment to viral stimulus and carcinogenesis, hence, we will examine DNA methylation and
immunological profiles to identify markers for cancer risk stratification after aHSIL. Examining local immune
responses may also shed light on targeted immunotherapeutic approaches and for better outcomes.
Additionally, given the disparities in anal cancer incidence and outcomes and the increasingly recognized
impact of social determinants on health, including in HIV care, HPV infection, and cancer screening, we will
examine whether social determinants play a pivotal role in aHSIL prevalence and clearance. We will recruit
500 minority men and women at high risk for anal cancer from Emory University and the University of Miami,
where we have a large portion of diverse populations, including US born Blacks, Caribbean Blacks, Latinx, and
MSM. We will follow them yearly for up to two years. Overall, the proposed study provides a unique
opportunity to examine the much-needed evidence on early aHSIL screening among high-risk minorities. The
methylation results will be crucial to stratify risks of screen-detected aHSIL and could be translated to
screening. The immune and inflammatory profile will identify alterations associated with neoplastic progression
and subsequently inform targeted immune interventions for better outcomes. Documenting the importance of
social determinants will provide invaluable recommendations to reduce health disparities, improve screening
outcomes, and decrease the incidence of anal cancer among high-risk minorities.

Public health relevance
PROJECT NARRATIVE: Anal cancer is particularly high among certain groups; health disparity further contributes to this high risk among minorities. The proposed research will examine performance of emerging screening methods for aHSIL (precancerous condition of anal cancer) among minorities with a high risk of anal cancer, as well as characterize DNA methylation, immunologic response, and social determinants associated with aHSIL, most likely to progress to cancer. Findings will provide much-needed evidence for anal cancer screening strategies to reduce health disparities, improve screening outcomes, and decrease the incidence of anal cancer among high-risk minorities.